A mentoring program for HIV prevention in pregnancy and postpartum

PROJECT SUMMARY
In this renewal application, Benjamin Chi, MD, MSc seeks dedicated support for research and mentorship of
patient-oriented researchers at the intersection of HIV, maternal and child health, and global health. This
proposal builds upon an impressive K24 track record to date: individual mentorship of 26 early-stage
investigators (including 10 NIH K awardees), work to enhance mentorship capacity in international academic
institutions, and high levels of research productivity. He seeks to build upon this successful mentoring program,
in ways that broaden impact and scope and are attuned to his current career stage. Candidate: Dr. Chi is a
recognized thought leader in the prevention of mother-to-child HIV transmission (PMTCT). He has led clinical
trials, observational cohorts, modeling studies, household surveys, and—with support in the first K24 cycle—
implementation research. Over the past five years, he has taken on leadership roles at his home institution, but
mentorship remains the cornerstone of his academic career. This award provides protected effort for such
activities, allowing him to refine his approach at a critical career juncture. Mentoring Plan/Environment: Dr. Chi
has an established track record in research training, including leadership of multiple NIH-funded initiatives. His
approach to mentorship has been highly productive but time-intensive. In this renewal, he introduces new
activities that foster group and peer mentoring, emphasize joint learning, and provide support for new mentors.
He will leverage UNC’s extensive resources to accomplish this goal, including NIH-funded centers and training
programs, networks and collaborations, and global health institutes and departments. This includes professional
development designed to improve his mentoring skills and support mentees on their path to research
independence. Research Plan: This proposal has a sharpened topical focus. HIV prevention for pregnant and
postpartum women is an emerging global priority in the field of maternal health and PMTCT; however, biological,
clinical, cultural, and social factors that are unique to these periods are often overlooked. Through mentored
research, this program seeks to develop this expertise in early-stage investigators. Three projects are described
that will collectively provide valuable insights about HIV risk and the use of HIV prevention interventions (in this
case, pre-exposure prophylaxis or PrEP) among pregnant and postpartum women. Scientifically, these aims
follow a rational and clear progression: (1) characterizing HIV risk among pregnant and postpartum women, (2)
describing the alignment of perceived HIV risk and PrEP use during these periods, and (3) designing and
assessing a new intervention to improve this alignment. Each of these studies build upon funded NIH research
led by Dr. Chi and his collaborators. They represent a body of work that will remain relevant as the HIV prevention
landscape continues to evolve. Importantly, this framework provides mentees with access to robust research
across three African countries, a multidisciplinary team of collaborators and co-mentors, and a rich learning
environment that spans two continents.

Public health relevance
NARRATIVE In this K24 renewal, Dr. Benjamin Chi proposes to continue his successful mentoring program focused on HIV prevention in pregnancy and postpartum. This research will provide new insights about how perceptions of HIV risk influence the use of HIV prevention interventions (in this case, pre-exposure prophylaxis) during these periods. It will also provide a platform to train promising, early-stage researchers in this emerging and important field.